SERTOLI CELL TOXICANT INJURY AND MECHANISMS OF TESTICULAR GERM CELL APOPTOSIS

PROJECT SUMMARY/ABSTRACT
The goal of this project is to decipher the functional role of testicular macrophages and other leukocytes in the
pubertal testis after exposure to the Sertoli cell toxicant mono-(2-ethylhexyl) phthalate (MEHP). Although these
cells have traditionally been known for their phagocytic and antigen presentation functions, there is a growing
body of evidence that these cells are critical for normal development, homeostasis and repair/regeneration of
tissues after toxicant injury. We have previously described a robust infiltration of CD11b+ immunoreactive cells,
representing macrophages, neutrophils, monocytes, natural killer and dendritic cells, into the testicular interstitial
space in pubertal aged rats (PND 28) after MEHP (700 mg/kg, p.o.) treatment. The most pronounced infiltration
of these cells occurs in pubertal rats, with lesser amounts in adult rats. Further, C57BL/6J mice at both ages do
not have a significant infiltration due to MEHP exposure. The species and age-dependent sensitivity of MEHP-
induced testicular injury is well recognized, although the mechanisms that account for these differences remain
unresolved. A detailed evaluation of the cells that lie adjacent to the basement membrane of the seminiferous
tubules revealed a specific testicular macrophage sub-population, the peritubular macrophages (ptMφs), that is
increased in number and in specific regional localization along the periphery of the seminiferous tubules for a
sustained period (>2 weeks) after MEHP exposure. The ptMφ subtype has gained attention in the field of testis
biology because they are predicted to play a critical role in the maintenance of the microenvironment supporting
the spermatogonial niche. These findings have led to the hypothesis that MEHP-induced Sertoli cell injury
incites an increase in the number and localization of distinct testicular macrophage subtypes as a
mechanism to facilitate the efficient repair and recovery of spermatogenesis. To test this hypothesis, the
first specific aim will characterize and determine the localization of macrophages subtypes in the pubertal testis
in response to a range of MEHP doses (from a low of 10 mg/kg with increased dose intervals of 100, 250, 500
or 700 mg/kg). In the second aim, the cellular mechanisms that induce an infiltration of leukocytes into the testis
will be defined. In the final aim, the extent that testicular macrophage subtypes are involved in mediating the
recovery of spermatogenesis after a sub-chronic low dose MEHP treatment regimen will be determined as a
strategy to more accurately translate the findings of this research project to human relevant exposures. Insights
gained from this work will be valuable for predicting individuals susceptible to toxicant-induced infertility and the
prevention of reproductive health risks associated with this ubiquitous environmental toxicant. Assessing the
individual susceptibility to interactions of environmental toxicants with the immune system is consistent with goals
of the NIEHS 2018-2023 strategic plan.

Public health relevance
PROJECT NARRATIVE The focus of this research proposal is to delineate the contribution of cells of the innate immune system (macrophages & monocytes) in the sequence of events that occur in the pubertal rodent testis after exposure to the Sertoli cell toxicant, mono-(2-ethylhexyl) phthalate (MEHP). Phthalates are a class of compounds used in medical and consumer products and, as a result, are found ubiquitously in the environment. The work of this research proposal is relevant to human health as it is anticipated to provide mechanistic insights that will be valuable for predicting and preventing human reproductive health risks to environmental toxicants.